Statistical Learning for Precision Medicine Based on Multi-Source Data

PROJECT SUMMARY/ABSTRACT
The pursuit of tailored treatment strategies for individual patients remains crucial for enhancing cost-
effectiveness in clinical practice. Despite advancements in statistical methodologies and machine learning,
persistent challenges impede the progress and implementation of precision medicine in clinical practice.
Limited sample sizes pose a significant hurdle in estimating individualized treatment effects on clinical
outcomes, necessitating the utilization of information from multiple data sources. However, effective integration
of such data requires appropriately addressing population heterogeneity, privacy constraint, and features
alignment across datasets. Furthermore, even with a group of well-developed prediction models of different
complexity in place, there is still a need to devise smart strategies for adaptively employing them in practice.
Lastly, addressing treatment effect heterogeneity in clinical trials remains challenging, particularly in efficiently
synthesizing information from both discovery and validation stages without introducing bias.
Our proposal aims to develop innovative solutions to aforementioned problems. First, we will introduce a novel
transfer learning approach to accommodate overlapping but non-identical prediction feature sets in source and
target populations. Second, we will develop a latent class model leveraging knowledge graph information from
multiple sources for flexible feature alignment. Third, an innovative dynamic prediction strategy will be created
to optimize the sequence of acquiring prediction features, thereby enhancing prediction accuracy while
minimizing measurement cost. Fourth, we will extend reinforcement learning at a single site to federated
learning setting under privacy constraints so that adaptive strategy such as personalized dynamic treatment
regimen can be better developed. Lastly, we will propose a comprehensive framework for integrating
information from both discovery and validation stages in studying the treatment effect heterogeneity, enabling
unbiased inference of treatment effects among a selected subgroup of responders.
All methodological developments will undergo rigorous numerical studies and real-data applications, ensuring
their effectiveness, and will be disseminated widely to benefit the clinical community.

Public health relevance
PROJECT NARRATIVE In this project, we will develop reliable and transparent statistical tools to promote the development and implementation of precision medicine in clinical practice. First, the proposed method aims to leverage knowledge and data from multiple sources to enhance our ability to recommend the best treatment option for each individual patient. Second, to facilitate the practical use of precision medicine strategy in clinical setting, t he proposed method also allows dynamic decision making on whether to make a risk prediction and treatment recommendation for individuals based on available information or to collect more information before making a final decision.